Evaluating Huddles as a Novel Approach to Improving Concussion Safety

PROJECT SUMMARY
More than 1 million US youth sustain a concussion each year during sports, yet up to 50% do not report symptoms to
an adult, resulting in risk of further injury and prolonged recovery. To address these concerns, youth sport
organizations mandated annual concussion education for athletes and coaches, but such approaches have not led to
increases in concussion reporting as they: (1) focus on concussion knowledge, despite research indicating that changing
knowledge alone does not shift concussion reporting (2) target individuals rather than systems, despite evidence
suggesting interpersonal and group processes are the primary drivers of concussion reporting and (3) are delivered once
at the beginning of the season, despite the importance of message recall and salience for behavior change. We have
developed a novel systems-level approach to improving concussion safety, bringing both teams together prior to a
game in a “Huddle” to remind youth athletes of the symptoms of concussion and affirm the importance of reporting
symptoms to an adult if injured. Huddles take just a few minutes and provide a formalized opportunity for coaches to
establish norms supportive of concussion reporting and removal from play in the setting where reporting will occur,
and a mechanism for reinforcing this support throughout the season. Unlike more resource intensive and static
concussion education interventions, a strength of Huddles is their brevity and adaptability, which makes them well
positioned for equitable scalability and sustainability across youth sport settings. We created and tested this
intervention using mixed methods in collaboration with coaches, athletes, parents, and officials in youth soccer and
football in Georgia and Washington, finding broad acceptability and evidence for efficacy. We now plan to utilize a
Hybrid Type I mixed methods design with a large sample of male and female youth soccer players in four US states to
assess effectiveness of Huddles and identify barriers and facilitators to implementation. We thus propose the following
aims: (1) Assess the effectiveness of Huddles using a cluster randomized controlled trial with randomization at the
league-level (i.e., closed group of teams that compete against each other) and a primary outcome of proportion of
athletes who sustained a potential concussive injury who reported their symptoms to an adult; (2) Test the theory-
driven mechanisms hypothesized to explain Huddles effectiveness, particularly perceived norms related to concussion
reporting; (3) Using a mixed-methods approach identify determinants of successful implementation and maintenance at
the team and league level, including exploring the impact of
community-level socioeconomic characteristics and other contextual factors. We strongly believe that ensuring
concussion educational approaches function to improve athlete safety is a public health imperative. At the conclusion
of this study, we will have critical information about the effectiveness of Huddles for improving concussion safety in
youth soccer, and Huddles will be well positioned to be scaled and adapted across a broad range of youth sports.

Public health relevance
PROJECT NARRATIVE Millions of youth play sports with risk of concussion, and all are required to receive some form of concussion education. Ensuring concussion education functions to equitably improve athlete safety is a public health imperative. This project will provide critical information about the effectiveness and implementation of Huddles, a promising systems-level approach to concussion education that involves brief coach led messaging about concussion reporting before every game.